Administrative Core

ABSTRACT
Administrative (ADMIN) Core
Cognitive Neuroscience of Development and Aging (CoNDA) Center
The Administrative (ADMIN) Core of the Cognitive Neuroscience of Development and Aging (CoNDA)
Center plays a pivotal role in leading, implementing, and supporting the Center's key activities. These activities
include establishing essential infrastructure for (1) studying neurocognition in human subjects using
neuroimaging approaches, and (2) using preclinical models to study neurodevelopmental and
neurodegenerative disorders using imaging and behavioral assessment. The mission of the ADMIN Core is to
continue to provide effective organizational structure and a coordinated administrative framework to guarantee
optimal management, utilization, evaluation, and oversight of this COBRE in Phase II. This infrastructure
developed during Phase I facilitates the Center's goal to provide mentoring to promising new investigators
dedicated to advancing innovative approaches for neurological disease treatment. The specific aims of the
ADMIN Core are to: 1) provide effective administrative and programmatic leadership for the CoNDA Center, 2)
grow the critical mass of investigators conducting neuroscience research and provide integrated training and
mentoring infrastructure, and 3) implement an evaluation plan for all components of the CoNDA Center. The
ADMIN Core offers organizational and programmatic leadership to ensure the CoNDA operates efficiently to
achieve its goals and remains responsive to emerging research opportunities, enhancing overall effectiveness.
ADMIN Core coordinates a faculty development plan, including a Research Project Program and Pilot Grant
Program, designed to expedite the transition of accomplished Research Project Leaders (RPL) to independence.
Ongoing implementation of Center-wide initiatives, such as monthly Research Development Forum, an annual
colloquium, and support for external seminar speakers, fosters a collaborative research environment. This
approach not only promotes the CoNDA on the national stage but also supports the development of Team
Science approach of multi-investigator grants. Additionally, it provides support to research programs and
scientific cores, aiding in providing state-of-the-art tools for neuroimaging and behavioral assessment while
offering guidance in experimental design and data analysis.